Assessing the Impact of dTMS on Neural Targets Associated with Alcohol Use Disorder

ABSTRACT
Background: Converging lines of evidence suggest that neuromodulation of the neural mechanisms
underlying alcohol use disorder (AUD) are an innovative next step in improving treatment outcomes and
reducing risk of relapse. Emerging research supports the salience network (SN) as a promising target to
accomplish these goals. Deep transcranial magnetic stimulation (dTMS) is one type of neuromodulation
technique that allows for deeper stimulation of cortical neurons, thus reaching core nodes of the SN, such as
the dorsal anterior cingulate cortex (dACC). Objective: The aim of this proposal is to 1) evaluate the efficacy of
active dTMS in increasing dACC activation and reducing drinking relative to a sham (placebo) condition, 2) to
assess the trajectory of target engagement changes (i.e., increased dACC activation) that are evident after 15
sessions versus 30 sessions, and 3) evaluate the durability of the neural changes and how this might impact
treatment outcomes (i.e., % days abstinent and % heavy drinking days). Methods/Design: We will enroll 100
adults with AUD into a 2-arm randomized, double-blind, sham-controlled mechanistic trial to confirm target
engagement relative to sham, assess the impact of the protocol on drinking behaviors, and determine
moderators of treatment response. Participants will be randomized in a 1:1 ratio to receive either 30 sessions
of active 20Hz dTMS to the mPFC and dACC using the H7 coil, or an equivalent sham condition. Participants
will receive 3 dTMS treatments per day for 10 consecutive business days (30 total treatment sessions) and will
complete neuroimaging assessments at baseline, after one-half of treatment sessions, post-treatment and 1
month after treatment. Specific Aims: We aim 1) to evaluate the efficacy of active dTMS relative to sham
dTMS in reducing 3-month post-treatment drinking rates and target engagement, 2) evaluate the relationship
between degree of target engagement to drinking rates and identify individual variability in target engagement
trajectory, and 3) to evaluate the association of target engagement durability of dTMS for relapse prevention.
Impact: The proposed research will elucidate mechanisms of brain and behavior change, accelerate the
development of new, device-based, treatment options and will be the basis for developing a large-scale, dose-
varying, clinical trial to test new treatment strategies for AUD.

Public health relevance
PROJECT NARRATIVE Converging lines of research support the utilization of deep transcranial magnetic stimulation (dTMS) as a novel, non-pharmacologic approach to improving treatment outcomes for those with alcohol use disorder (AUD) by modulating neural circuits related to relapse. The results of this study will be used to determine the efficacy of dTMS on changing brain function and drinking, whether we can identify individuals who will respond earlier to the intervention, and how long the changes might last. These data will set the foundation for more in- depth investigations of dTMS to be used as an innovative, new treatment option for individuals with AUD.